Technology Core

Project Summary - Technology Core
The Center for Viral Systems Biology (CViSB) requires the generation of large, multivariate datasets, many
of which necessitate modifying existing experimental and computational approaches or creating novel
methods. The Technology Core’s primary responsibility is providing state-of-the-art, high throughput
omics and functional services to support CViSB’s Projects. We will leverage our considerable expertise
and experience with these techniques and, to ensure that we maintain our position as a cutting-edge
experimental facility, we will identify, develop and adapt emerging technologies with the potential to
further CViSBs scientiﬁc aims. We will then translate these innovative experimental approaches into
standardized protocols and methods that are suitable for distribution and reuse. To accomplish these
objectives and support the overall mission of CViSB, we have the following four aims: (1) Evaluate,
develop, and improve experimental methods and analysis tools for multi-omics analysis of host adaptive
immune function; (2) Develop and improve cost-eﬀective next-generation methods for large-scale virus
sequencing; (3) Provide cutting-edge sequencing and omics services to support the data generation
needs of CViSB’s Projects and investigators; and (4) Create and distribute open access standard operating
procedures, protocols, and methods.